Defining the contributions of amygdalar circuits to the metabolic responses to homeostatic challenge

Our long-term goal is to understand the contribution of stress-induced neural signals to glucose regulation and
the development of metabolic diseases with the aim of developing better therapies. To achieve this goal, we
need a more detailed understanding of the neural circuits modulated by internal and external signals that, in turn,
regulate metabolic function. In this proposal, wewill create a detailedand systematic analysis of the activity of
specific amygdala neural populations in response to stress, determine their physiological roles, identify genetic
markers for stress-responsive neural populations with defined projections and assess the contribution of these
populations to metabolic regulation in acute and repeated stress. Our pilot data strongly support the activation
of specific populations of amygdala neurons in response to stressors and chemogenetic activation of these
neurons and circuits rapidly and robustly increases blood glucose. Our proposal will create new insights into the
neural populations and circuits that regulate metabolism bring
an unprecedented level of precision and specificity by combining cell-type specific neural tracing, spatial
transcriptomics and targeted neuromodulation in which we have extensive experience. Without this detailed
knowledge, our understanding the contribution of defined amygdala circuits to metabolic responses to stress will
remain incomplete. The overall objective of this proposal is to understand the structure, genetic composition
and function of defined amygdala circuits. Our central hypothesis is that defined medial amygdala neural
populations and their hypothalamic projections are critical to the metabolic responses to stress. The rationale
that underlies the proposed research is that internal and external stressors result in profound metabolic
responses. However, we do not know the activity or genetic identity of the activated neural populations, their
downstream circuits, or physiological roles. These represent major gaps in our understanding. To test our central
hypothesis and attain the overall objective, we will a) determine the activity and physiological roles of defined
medial amygdala neurons in the glucose response to acute and repeated stress and b) identify the neural activity,
function and gene markers for specific downstream circuits that regulate blood glucose in responses to acute
and repeated stress. To do so, we will use in vivo calcium imaging to assess neural activity, cell type and circuit-
specific neuromodulation to define physiological roles of defined amygdala circuits in the regulation of glucose
with stress, and spatial transcriptomics to identify gene markers for neural populations with defined projections
contributing to glucose regulation in stress. The proposed studies will provide a comprehensive understanding
of the unique biology of medial amygdala circuits regulating metabolic function in response to acute and repeated
stress to form a crucial foundation for future studies to identifying potential therapies for stress-associated
metabolic diseases such as type 2 diabetes.
in response to homeostatic challenges. We will

Public health relevance
Project Narrative The proposed research is relevant to public health because it focuses on determining the role of defined amygdala neural populations in regulating metabolism in response to homeostatic challenges. This information is a critical foundation to translational studies to identify neural circuits relevant to the development and treatment of metabolic disease. Thus, the proposed research is relevant to the part of the NIH's mission that pertains to reducing illness and disability.